Planning & Evaluation Core

The Partnership for Native American Cancer Prevention’s (NACP) Planning and Evaluation Core (PEC) serves each of the NACP components by ensuring that they demonstrate impactful progress toward the overall goals within the 22-year partnership between the Northern Arizona University (NAU) and the University of Arizona Cancer Center (UACC). Moreover, during this new funding period, the PEC will expand on the experience and relationships developed throughout the duration of NACP’s existence to incorporate community priorities. This will be accomplished through a two-eyed seeing framework – leveraging AIAN and contemporary scientific perspectives – the research projects will address cancer priorities of AIAN communities.
PEC interacts with five entities to provide expert, unbiased, rigorous evaluation of NACP progress and recommend improvements and new directions as the NACP continues to evolve. These entities include: NACP’s Executive Committee (EC) made up of the multiple Principal Investigators (MPIs), Core/Shared Resource Co-Leaders, the Evaluator and Partnership Managers; the Internal Advisory Committee (IAC) consisting of research and education leaders from both NAU and UA outside the direct responsibilities of NACP; the Community Advisory Board (CAB), composed of community members that hold leadership positions within their communities and/or are involved in cancer health-related AIAN initiatives; the Program Steering Committee (PSC), an external advisory board comprised of nationally-recognized experts in cancer research, training of biomedical researchers, and the officers and leaders of the National Cancer Institute. Additionally, innovations this cycle include building evaluation leadership, incorporation of the two-eyed seeing framework in evaluation and community engagement, and enhanced cross-institution matchmaking. With this expertise and novel approaches, PEC will address the following Specific Aims:

Aim 1. Maintain and expand a comprehensive evaluation feedback system to support data-driven decision-making for program improvement and innovation.
Aim 2. Collaborate with five entities (EC, IAC, CAB, PSC, NCI) to engage in internal and external planning and assessment of NACP’s activities and outcomes, with the goal of continual improvement in the NACP’s ability to achieve its overall goals.
Aim 3. Direct the solicitation, development, and selection of new cancer health focused research projects that are responsive to the needs and priorities of AIAN communities, as well as monitor the scientific progress and productivity of active research projects.